The effect of inherited maternal cells on BCG-specific T cell responses in HIV exposed and unexposed infants

SUMMARY
Each year, nearly 1.3 million exposed but uninfected infants (iHEU) are born. Compared to infants who were
unexposed to HIV in utero (iHU), iHEU experience greater morbidity and mortality associated with infectious
diseases, including Mycobacterium tuberculosis (Mtb) infection. To prevent disseminated Mtb in childhood, most
infants born in Mtb-endemic settings receive bacille Calmette-Guerin (BCG) vaccine early in life. CD4+ T cell
responses, particularly from the Th1 subset, are critical for controlling tuberculosis and are therefore used as a
proxy for BCG vaccine immunogenicity. However, altered CD4+ T cell recall responses to BCG have been
observed in iHEU, suggesting that the benefits of BCG may be reduced in these infants. As such, a more
complete understanding of the factors influencing CD4+ T cell recall responses to BCG are critical to improve
tuberculosis vaccination strategies in infants living in settings with high Mtb and HIV prevalence. Maternal
microchimerism (MMc) at birth refers to the transmission of maternal cells to the offspring in utero, and we
recently found in a cohort of South African infants that birth MMc strongly predicted BCG-specific recall CD4+ T
cell responses during infancy. However, iHEU, and in particular those born to mothers who initiated antiretroviral
therapy (ART) during pregnancy (“late ART”), had lower MMc at birth. Based on our preliminary data, we
hypothesize that the reduced transmission of MMc in utero may function as an unrecognized mechanism of
altered BCG-specific responses in iHEU. Work in animals indicates that the impact of MMc on offspring immunity
may be mediated via either antigen-specific or antigen-independent effects. Based on these observations, we
hypothesize that birth MMc is associated with improved infant BCG-specific CD4+ T cell recall responses through
two potentially complementary mechanisms: i) by inducing mycobacterium-specific accentuation of the primary
infant T cell responses to BCG and/or ii) by bolstering trained innate immunity in the infant leading to improved
T cell responses. We further hypothesize that these mechanisms are restricted in iHEU versus iHU and
particularly diminished within iHEU whose mothers initiated ART during versus prior to the pregnancy. To test
these hypotheses, we will investigate the impact of MMc on infant CD4+ T cell BCG-specific responses using
previously collected samples and data from iHEU and iHU enrolled in the InFANT cohort in South Africa. We will
first determine the impact of maternal HIV exposure and ART timing on the in utero transmission of
mycobacterium-specific T cells and polyfunctional T cell BCG recall response. We will next assess the
relationship between birth MMc, trained immunity, and BCG-specific T cell recall response in iHEU and iHU.
These studies will utilize previously collected samples and data from the InFANT cohort to elucidate the
mechanisms underlying the association between MMc and improved BCG vaccine responses in iHEU and iHU,
empowering future strategies to maximize protection against tuberculosis.

Public health relevance
NARRATIVE Bacille Calmette-Guerin (BCG) vaccine early in life can prevent disseminated tuberculosis in children; however, CD4 T cell responses to BCG vaccination are attenuated in HIV exposed but uninfected infants (iHEU). We recently found that maternal microchimerism was associated with improved BCG responses in South African infants and that iHEU had lower levels of maternal microchimerism. These studies will elucidate the mechanism(s) underlying the association between maternal microchimerism and improved BCG vaccine responses, empowering future interventions to optimize protection against tuberculosis in children in areas with high HIV prevalence.